Role of TBK1/IKK epsilon inhibition in pancreatic beta cell regeneration

Diabetes mellitus is characterized by impaired glucose homeostasis resulting from insufficiency or functional failure of insulin-producing β?cells, alone or in association with insulin resistance. Therefore, restoring β-cell mass and function is essential to reverse the development of diabetes. Utilizing small molecule inducers of β-cell proliferation is a particularly promising strategy with numerous valuable features such as their oral bioavailability and target specificity. However, the slow rate of β-cell proliferation in adult humans is a major hurdle to overcome to use this approach. Through a chemical genetic screen for small molecule enhancers of β-cell regeneration in zebrafish, we identified several TBK1/IKKε inhibitors (TBK1/IKKε-Is). TBK1/IKKε-Is promoted β-cell regeneration by markedly increasing proliferation of β-cells. Mammalian target of rapamycin (mTOR) inhibitor rapamycin eliminated the effect of TBK1/IKKε-Is on regenerating β-cells, whereas TBK1/IKKε-Is augmented mTOR activity. Interestingly, treatment with TBK1/IKKε-Is led to pronounced increase in cAMP levels. The proliferation effect of TBK1/IKKε-Is was verified in primary mammalian islets including human islets. The goal of this application is to delineate the mechanisms and the strategies of how to increase functional β-cell mass with suppression of TBK1/IKKε. First, we will design and investigate the potency of novel TBK1/IKKε-Is on β-cell regeneration. Using (E)-3-(3-phenylbenzo[c]isoxazol-5-yl)acrylic acid (abbreviated as PIAA), which markedly increases β-cell regeneration, as a lead compound, we will perform structure-activity relationship (SAR) analyses of TBK1/IKKε-PIAA interaction. Furthermore, we will use the PIAA as a scaffold to design new molecular architectures that exhibit potent and selective TBK1/IKKε inhibition activities with minimum toxicity on β-cell regeneration. Second, we will elucidate underlying mechanisms of TBK1/IKKε-mediated β-cell regeneration. Given that rapamycin treatment abolished the effect of TBK1/IKKε suppression on β-cell regeneration and TBK1/IKKε-Is enhanced mTOR activity and cAMP levels, we will test whether TBK1/IKKε suppression promotes β-cell regeneration via modulating the cAMP-mTOR signaling cascade. We will perform biochemical and functional analyses to characterize the TBK1/IKKε-cAMP-mTOR interplay on β-cell regeneration in vitro and in vivo. Third, we will investigate the efficacy of TBK1/IKKε-Is on expanding functional β-cell mass in mammalian systems. We will use primary pancreatic islets to examine the potency of PIAA and its newly synthesized analogs on β-cell replication. Furthermore, we will evaluate the ability of PIAA and its analogs to promote β-cell expansion and enhance glycemic control in mice including a mouse model of streptozotocin (STZ)-induced diabetes.

Public health relevance
We will delineate the mechanisms and the strategies of how to augment functional β-cell mass by repressing TBK1/IKKε function. The outcomes of the proposed study will make a significant breakthrough to prevail over the current bottleneck of enhancing human β-cell proliferation in treating diabetes.